Biobehavioral perspectives on social connectedness and the âMindful Momsâ intervention for marginalized pregnant women with depression

PROJECT SUMMARY/ABSTRACT
Background: Nearly 20% of women in the United States experience clinically significant depressive symptoms
during pregnancy or the postpartum period. Although treatments exist for depressive symptoms such as
antidepressants and psychotherapy, many women remain under- or un-treated due to concerns about stigma,
side effects, and costs, particularly marginalized women (minority, low socioeconomic status). Further, the
standard depression treatments do not address social connectedness, which is a potentially modifiable factor
involved in depressive symptoms. A focus on adequate symptom management through safe, non-
pharmacologic, accessible therapies that address social connectedness during pregnancy in marginalized
women is an urgent clinical and research priority. Preliminary Data: Preliminary evidence from our research
team shows a promising pathway for addressing social connectedness in the context of perinatal depression:
we have piloted the “Mindful Moms” intervention in a NICHD-funded study (R15HD086835, Kinser); the 12-
week intervention involves a brief motivating discussion about symptom self-management plus group-based
mindful physical activity (prenatal yoga) sessions. Study findings provide support of protocol feasibility and
intervention acceptability, with qualitative findings leading us to hypothesize that social connectedness plays as
a key role in symptom management. Also, we have identified epigenetic patterns uniquely related to
postpartum depression; we will evaluate the similarity of these DNA methylation patterns related to social
connectedness and postpartum depression, as an exploration of mechanisms of social connectedness. Study
Design: Using a conceptual framework based upon Individual and Family Self-Management Theory, the overall
goal of this two-arm longitudinal randomized controlled trial is to evaluate the effects and mechanisms of this
self-management approach in marginalized women with depressive symptoms (n=200), compared to an active
control. The first Specific Aim is to evaluate effects by group on depressive symptom severity, anxiety, and
perceived stress over time. The second Specific Aim is to understand the role of social connectedness as a
moderator of the effects of group assignment on depressive symptoms. The third Specific Aim is to identify
genome-wide DNA methylation patterns associated with levels of perceived social connectedness. Potential
Impact: The successful completion of our aims will provide important insights into social connectedness as a
mechanism to decrease depressive symptoms in a largely understudied, historically marginalized population of
women. Further, if proven efficacious, “Mindful Moms” may be a low-cost, sustainable, and translatable option
for intervention in perinatal depressive symptoms.

Public health relevance
PROJECT NARRATIVE/ RELEVANCE TO PUBLIC HEALTH Nearly 20% of women in the U.S. (1 million women per year) experience clinically significant depressive symptoms during the perinatal period (pregnancy and postpartum), and social connectedness may be a modifiable factor involved in symptom persistence. A promising self-management approach called Mindful Moms has been developed and tested in our team’s pilot studies; we propose to build upon this work by evaluating Mindful Moms through a randomized controlled trial with marginalized women (minority, low socioeconomic status) who often suffer “in silence” due to various barriers in care. The successful completion of this study will provide important insights into social connectedness as a mechanism to decrease depressive symptoms in a largely understudied population.